Training in Pharmacological Sciences

Project Abstract:
This renewal application requests twelve training slots to support graduate students in the Harvard Therapeutics
Graduate Program (TGP) during their second and/or third year of training. Demographic trends are increasing
the need for targeted drug treatments, and there is growing optimism for treating historically untreatable diseases
based on recent scientific developments in areas such as inflammation and the emergence of new drug
modalities such as antibodies and oligonucleotides. Many research schools and hospitals are building
translational research centers, often in collaboration with local industry, and these need to recruit well-trained
faculty and PhD-level staff. The biopharma industry has exploded in Massachusetts in the last decade, and many
PhD-level positions remain unfilled. The TGP seeks to train the next generation of leaders in these fields and
recruits students from all 13 Harvard Integrated Life Sciences (HILS) PhD programs to build a diverse and
inclusive community of scholars committed to translational biomedical research and development. Our program
consists of a robust required core curriculum, paracurricular activities focused on professional skills
development, and a signature required internship, where students spend 2–4 months in an industrial or
regulatory science setting, usually by the end of their 4th year. Through these programmatic elements, trainees
receive exceptional intellectual, practical, and professional skills development focused on the science of drug
discovery, evaluation, and equitable clinical use and distribution. Paramount to our training goals is a strong
emphasis on research rigor, reproducibility, and the ethical conduct of science. TGP faculty, recruited from
multiple HMS and Harvard programs, including the Biological and Biomedical Sciences (BBS), Chemical Biology,
and Systems Biology graduate programs at Harvard Medical School (HMS), Harvard University, and the HMS-
affiliated teaching hospitals, will be evaluated for the scientific relevance of their research, their mentoring skills,
and their commitment to student-centric training experiences. Central to our mission is to help diversify the
biomedical research pipeline and add intellectual diversity to research endeavors. The TGP boosts resilience of
minoritized student groups through career preparedness, and highlights the importance of translational research
in health equity and social justice. Furthermore, trainees are granted access to many industry professionals and
networking opportunities in our courses, paracurricular activities, and the required internship. In conjunction with
institutional efforts, our training platform helps to bend the arc of graduate training towards student-centric
modalities and train future scholars to be pioneers in therapeutic science.

Public health relevance
Project Narrative. The Harvard Therapeutics Graduate Program (TGP) will train PhD students for academic and industry careers in the discovery, evaluation, and safe clinical use of drugs. This interdisciplinary program will recruit students from multiple Harvard PhD programs to build a diverse and inclusive community focused on therapeutic science, with a strong emphasis on professional skills development and career mentoring in addition to rigorous science.